Genome evolution across complex trait hierarchies

Project Summary
Most human health traits are highly complex and hierarchical, in which a high-level trait (e.g., energy expenditure)
is the product of the combined effects of a suite of sub-phenotypes. These trait hierarchies are typically
influenced by many genetic variants of small effect that interact with one another and with environmental factors,
making the identification of the causative variants a significant challenge. As a result, past research strategies
have largely failed to fully address the complexity of most complex traits, leaving a significant knowledge gap in
our understanding of the genetic basis of these traits. This project will use an innovative combination of a large
multiparent mapping population and experimental evolution using the powerful fruit fly model system to identify
the common mechanistic connections between complex traits and observe how these connections influence
multitrait evolution. First, this project will simultaneously evolve flies targeting multiple trait hierarchies and track
the genomic and phenotypic changes that occur during adaptation. Second, this project will leverage a large
multiparent mapping population that has been used broadly in the genetics community to address fundamental
questions about the generality of emergent properties of the genome, such as the extent of pleiotropy, genotype
by environment interactions, and genetic background effects. Overall, this research will provide generalizable
lessons about how genomes are connected to physiology to produce the interconnected set of traits that affect
health across the lifespan.

Public health relevance
Project Narrative Precision medicine promises to customize medical care to the individual patient based on their genome and individual environment and behaviors. However, we lack a basic understanding of the causal connections between the genome and complex trait hierarchies, in which a suite of sub-phenotypes all contribute to produce a high-level phenotype. This research will use a model system to provide general insights into trait hierarchies, with relevance to many health-related trait hierarchies, such as coronary artery disease, exercise endurance, or metabolic syndrome.